Scavenging IsoLGs in Autoimmune Disease: a proof-of-concept clinical study

Systemic lupus erythematosus (SLE) is an inflammatory autoimmune disease with a
markedly increased prevalence of not only hypertension but also resistant hypertension.
Hypertension, along with other factors, leads to a 2 to 3-fold increase in risk of cardiovascular
disease in SLE. Other than glucocorticoids and immunosuppression, there are few therapeutic
options for patients with SLE and none that are known to have a beneficial effect on hypertension
and cardiovascular disease; in fact, glucocorticoids have substantial deleterious effects. The
increased prevalence of hypertension and its greater severity in SLE patients are unexplained;
however, work from our group and others increasingly implicates activation of the immune system
in the pathogenesis of hypertension. Moreover, our data suggest that downstream products of
oxidative stress, specifically isolevuglandins (IsoLGs), drive immune activation and hypertension.
IsoLGs are highly reactive dicarbonyl products of oxidative stress that bind covalently to
proteins causing conformational changes rendering them immunogenic and proinflammatory.
Two decades of work at Vanderbilt led to the identification of 2-hydroxybenzylamine (2-HOBA) as
a highly effective scavenger of reactive dicarbonyls such as IsoLGs. Scavenging reactive
dicarbonyls is preferable to using antioxidants because reactive oxygen species are necessary
for normal cellular function. In animal models of SLE, hypertension, and atherosclerosis 2-HOBA
reduced inflammation, neutrophil extracellular traps (NETosis), blood pressure, and
atherosclerosis, and in human phase I clinical studies with healthy volunteers it was well tolerated.
We propose a mechanistic, proof-of-concept phase II study with a randomized, placebo-
controlled, double-blind, cross-over design to determine the effect of IsoLG scavenging by 2-
HOBA on blood pressure and immune activation in patients with SLE. 42 patients with stable SLE
and elevated blood pressure will be randomized to treatment sequence to receive placebo or
750mg 2-HOBA three times a day for 8 weeks followed by a 4-week washout and then 8 weeks
of the other agent. Comparing 2-HOBA and placebo arms, Aim 1 will determine the change in 24-
hour blood pressure and Aim 2 will determine the change in immune activation measured by
NETosis and type 1 interferon score.
This study will provide mechanistic information on the role of IsoLGs in autoimmune
disease-associated hypertension and immune activation. In the long-term it may lead to a new
therapeutic with novel mechanism of action to treat both hypertension and autoimmune diseases.